Clinical and Translational Science Collaborative of Northern Ohio, Catalyzing Linkages to Equity in Health (CLE Health)

PROJECT SUMMARY/ABSTRACT
For the past 15 years, the Clinical and Translational Science Collaborative (CTSC) at Case Western Reserve
University (CWRU) has linked clinical and translational research efforts at five independent institutions—
CWRU, Cleveland Clinic, MetroHealth System, University Hospitals of Cleveland, and Louis Stokes Cleveland
Veterans Affairs Medical Center. Two new partners (University of Toledo School of Medicine and Northeast
Ohio Medical University) are now being added to extend the CTSC’s reach across Northern Ohio. The CWRU
CTSC has a strong track record of enhancing the quantity and quality of Clinical and Translational Science
(CTS) among our partners by facilitating novel research paradigms, technologies, and training. Our CTSC has
developed a new generation of researchers, enhanced collaborations among investigators, streamlined
discovery by building partnerships among industry and community and organizational partners, and facilitated
many successful entrepreneurial startups. Building on this solid foundation, the CWRU CTSC proposes an
expanded focus on health equity, reflected in the project theme Catalyzing Linkages to Equity in Health (CLE
Health). Social, economic, and environmental disadvantages are linked to poor health outcomes and lead to
disparities in life expectancy, infant mortality, and rates of chronic conditions. Minority groups are often
underrepresented in clinical trials as well, meaning there can be insufficient data for understanding the
effectiveness or safety of new drugs, procedures, or health interventions for different populations. The overall
goals of this project are to 1) understand the fundamental barriers to optimal recruitment of underrepresented
groups in clinical trials and test and scale interventions aimed at breaking down these barriers to diversify
study engagement, 2) facilitate and expedite innovation in multicenter clinical and translational research by
fully integrating community and stakeholder partners and ensuring that this research represents the
experiences of all and results in health improvements for all, 3) disseminate and implement novel and
responsive research programs across clinical and community settings to advance access to health
interventions that aim to promote health equity, and 4) create and disseminate inclusive and high impact
educational and training programs for translational research professionals of all disciplines and levels, both in
clinical and community settings. The CTSC has designed a Strategic Management Core and six CTS research
and training Elements to accomplish these goals: Workforce Development, Community & Stakeholder
Engagement, Resources & Services, CTS Pilot, Health Informatics, and CTS Research Program. We are
committed to innovative and collaborative practice and dissemination of results so that everyone in Northern
Ohio—and beyond—can benefit from advances in CTS in our programs and discoveries.

Public health relevance
PROJECT NARRATIVE The Clinical and Translational Science Collaborative (CTSC) at Case Western Reserve University has created a solid foundation to enhance the quantity and quality of Clinical and Translational Science (CTS) among its partners. This proposal brings an enhanced focus on health equity reflected in the theme Catalyzing Linkages to Equity in Health (CLE Health) and expands its reach to research professionals and special populations through the addition of two new partners to join our core group of five independent collaborators. The CTSC’s collaborative interdisciplinary environment coalesces around a shared mission to improve health and eliminate disparities by 1) facilitating and expediting innovation in multicenter CTS, 2) supporting novel approaches that address gaps in CTS, and 3) training a robust, diverse CTS workforce at all levels.